Addressing Rural cancer Inequities through Scientific Excellence (ARISE)

ABSTRACT
The Addressing Rural cancer Inequities through Scientific Excellence (ARISE) program aims to provide
transdisciplinary and translational postdoctoral research training in rural cancer prevention, control, and
survivorship. To achieve health equity and reduce the highest cancer morbidity and mortality rates in the
nation, University of Kentucky’s (UK) behavioral cancer training efforts must develop a new generation of
collaborative and rigorous scientists. Led by two well-established cancer and health equity researchers with
extensive track records of training, ARISE will meet this critical need by providing multifaceted training
opportunities to well-qualified postdoctoral scholars in applied behavioral science, including intervention and
dissemination and implementation science. Training will emphasize translating knowledge of risk factors into
evidence-based behavioral interventions across the cancer spectrum (prevention to survivorship) for
vulnerable rural residents. ARISE postdoctoral trainees will select one of three thematic behavioral cancer
tracks: environment, risk behavior, and health care delivery. We will recruit two trainees, each year for a two-
year fellowship. The training program, based in the Center for Health Equity Transformation, will operate in
close collaboration with UK’s National Cancer Institute-designated Markey Cancer Center; Center for Clinical
and Translational Science; Center for Appalachian Research in Environmental Sciences; Office of Postdoctoral
Affairs; Office of the Vice President for Research and departments across UK’s 16 colleges. The 25
preceptors, co-mentors and methodology mentors include well-funded investigators in transdisciplinary
research with established collaborative relationships, representing diverse yet complementary areas of
expertise, including behavioral science; environmental carcinogenesis; clinical and translational research; and
intervention and implementation science. Additional mentoring includes geospatial analysis, mHealth and
cluster randomized designs. Each trainee will have a mentoring committee with one primary mentor in her/his
specified track and two secondary mentors with one from another track and a methodology mentor. Trainees
will participate in a rigorous, structured program that includes formal coursework, training in the responsible
conduct of research, and workshops and seminars. Trainees will gain career development experiences and
build a professorial network through scientific writing; presentations; grant preparation and review; and
leadership opportunities. Special programming designed to improve expertise in rural cancer disparities
includes research shadowing, experience, a personalized rural cancer patient experience, and attendance at
rural health disparities conferences. We will track trainee progress and mentor support through detailed
annual evaluation. ARISE will build a next generation of cancer behavioral researchers aiming to achieve rural
health equity.

Public health relevance
PROJECT NARRATIVE Among current T32 training programs for cancer prevention, control, and survivorship, few focus on health equity among rural populations and none focus on cancer in the rural, Appalachian population. Addressing Rural cancer Inequities through Scientific Excellence (ARISE) is a postdoctoral training program at the University of Kentucky that will be a collaboration among the Center for Health Equity Transformation (CHET), the NCI-designated Markey Cancer Center (MCC), Center for Clinical and Translational Science (CCTS), UK Center for Appalachian Research in Environmental Sciences (UK-CARES), six colleges and 10 departments to provide interdisciplinary training in behavioral cancer research focused on rural disparities. The training program will have three tracks, environment, risk behavior, and health care delivery and will provide didactic, research experience and mentoring.